Investigating a Novel Inhibitory Receptor in Regulating CAR-T Cell Persistence and Function

ABSTRACT
Chimeric antigen receptor (CAR)-engineered T cell therapy is a breakthrough immunotherapy for lymphoma.
Nevertheless, 40-60% of responding patients relapse, in part due to the poor persistence of CAR-T cells. In
this regard, our preliminary studies have identified the role of an inhibitory receptor that functions to restrict the
expansion and persistence of T cells. This proposal will test the hypothesis that similar to natural T cells, CAR-
T cells were also controlled by this inhibitory axis: in Aim 1, we will examine the causal role of this receptor axis
in impairing the therapeutic efficacy of murine CAR-T cells. In Aim 2, we will examine the expression of this
inhibitory receptor in human CAR-T cells and test effects of blocking this receptor in augmenting CAR-T
function. Together, these studies will guide future studies to develop potent therapeutics for improving the
clinical efficacies of CAR-T therapies.

Public health relevance
PROJECT NARRATIVE Chimeric antigen receptor (CAR)-engineered T cell therapy is a breakthrough immunotherapy for lymphoma, but poor persistence of CAR-T cells contributes to relapse. This study will unveil the role of a novel inhibitory receptor in regulating CAR-T cell persistence, thereby holding potential for improving the clinical efficacies of CAR-T therapies.